Anterior Cingulate Cortex to Dorsal Striatal Circuits in Compulsive-like Binge Alcohol Drinking

Project Summary/Abstract
This project proposes to investigate the underlying neural mechanisms within the dorsal striatum driving the
development and maintenance of compulsive-like binge-drinking, or consumption of alcohol despite known
negative consequences, using chemogenetics and awake-and-behaving electrophysiology in male and female
C57BL/6J mice. Despite the established functional relationship of the prefrontal cortex inputs into the
dorsomedial striatum (DMS) for goal directed behaviorally flexible alcohol drinking and the dorsolateral striatum
(DLS) in compulsive behaviorally inflexible alcohol drinking, the circuit level shift in control of modulating the
development of compulsive-like alcohol drinking has not been defined, which limits prevention and treatment of
alcohol use disorder (AUD). The major hypotheses of this project are 1) the development and maintenance of
compulsive-like alcohol drinking relies on DLS mechanisms of potentiation from anterior cingulate cortex (ACC)
excitatory inputs which are facilitated by reduced ACC-DMS input and 2) that neuronal activity in the DMS and
DLS will differ based on alcohol drinking history, bull all mice will increase activity in the DLS and compulsive-
like mice will have greater DLS activity than DMS activity. The proposed project will assess the neural
mechanisms underlying home cage compulsive-like binge-drinking using drinking-in-the-dark during
chemogenetic inhibition from the ACC-DMS and ACC-DLS and through awake-and-behaving
electrophysiology recordings in the DS during compulsive-like alcohol drinking. The training plan for this project
is curated in an ideal research environment, engaging collaboration between both Indiana University – Purdue
University Indianapolis and the Indiana Alcohol Research Center to provide training in cutting edge
neuroscience techniques, professional development, and research ethics that will facilitate my career as an
independent scientist. The specific research hypotheses are 1) ablation of the excitatory projections from the
ACC to the DMS will cause alcohol naïve mice to develop and alcohol history mice to increase compulsive-like
alcohol drinking across drinking sessions. 2) Ablation of the excitatory projections from the ACC to the DLS will
cause alcohol naïve mice to prevent development and alcohol history mice to attenuate compulsive-like alcohol
drinking across drinking sessions. 3) Alcohol naïve and alcohol history mice will differ in their pattern of
neuronal activity, with relatively increased activity in the DLS and relatively decreased activity in the DMS
across drinking sessions in association with a compulsive-like alcohol drinking phenotype. Completion of the
proposed work will elucidate understanding of the mechanisms and neural circuits underlying the development
and maintenance of compulsive-like alcohol drinking and will serve to inform researchers in the field of
addiction neuroscience, leading to increased understanding and ultimately improved prevention and treatment
of AUD.

Public health relevance
Project Narrative Compulsive-like alcohol drinking, defined as drinking despite knowledge of negative consequences, is a phenotype of alcohol use disorder (AUD) in which the neural mechanism is incompletely understood, resulting in an impediment for the development of prevention and treatment of AUD. The research proposed here aims to 1) manipulate corticostriatal circuitry, specifically the anterior cingulate cortex (ACC) to the dorsomedial (DMS) and dorsolateral striatum (DLS) to understand the mechanisms driving the development and maintenance of compulsive-like alcohol drinking, and 2) directly record neuronal activity in the DMS and DLS in association with the compulsive-like alcohol drinking phenotype. Completion of the proposed project will improve our understanding of the neural mechanisms underlying compulsive-like alcohol drinking, as well as provide extensive training in cutting edge research techniques, professional development, and research ethics, ultimately providing fundamental training in preparation for a career as a research scientist.